Mechanisms controlling retinal responses to natural stimuli

Summary and expected impact
The proposed experiments will provide a clearer picture of the mechanisms that shape
responses to natural stimuli in the primate retina. Preliminary results suggest several important
insights. Aim 1: We find that standard models fail to account for responses of On parasol cells to
natural images. These are among the best-studied ganglion cells, and the inability of standard
models to account for their responses is surprising. Specifically, our results suggest that the
manner in which these cells integrate signals across space is highly stimulus-dependent in a
manner not captured by current models. Aim 2: We find that receptive field subunits - long
associated with bipolar cells - have more diverse properties than previously appreciated, likely
reflecting contributions of cells other than bipolar cells. In particular, light-dependent changes in
subunit size will be important to consider in evaluating the functional role of subunits. Aim 3: A
tool that we recently developed reveals significant contributions of post-photoreceptor
mechanisms to the kinetics of retinal ganglion cell responses.

Public health relevance
Project Narrative Our understanding of how the retina neurons works fails to account for responses to natural images—the stimuli for which the system evolved to work. The proposed work will improve our understanding of this issue. This is a requisite step in identifying the role of key circuit mechanisms in normal and aberrant natural vision and in the design of devices such as retinal prostheses to replicate or replace the retina.